Collaborating Consortium of Cohorts Producing NIDA Opportunities (C3PNO)

ABSTRACT In response to the Notice of Special Interest (NOSI) regarding the Availability of Administrative Supplements and Urgent Competitive Revisions for Research on the 2019 Novel Coronavirus (Notice Number NOT-DA-20-047 and linked Program Announcement PA-18-591) funding opportunity, the Collaborating Consortium of Cohorts Producing NIDA Opportunities (C3PNO; U24DA044554) proposes to assess the impact of COVID-19 on the participating cohorts - including people who use drugs (PWUD), people living with HIV (PLWH), and those at high-risk for HIV infection. We propose to expand the C3PNO COVID-19 module developed under a previous supplement (4U24DA044554-03:S2) to include vaccination attitudes, uptake, and adherence as well as post- COVID-19 symptoms and syndrome. The new module will allow further longitudinal assessment of the practice of protective behaviors, testing, substance use, and mental health in the C3PNO cohorts for at least two more rounds six months apart resulting in two years of data related to COVID-19 pandemic experiences. This approach will allow us to longitudinally assess vaccination hesitancy/acceptability and structural factors' association with uptake and adherence to COVID-19 vaccination. Additionally, we will use our current infrastructure and C3PNO validated harmonization strategies to compile new and existing data across the cohorts in order to: assess changes in social and individual determinants of health during the course of the COVID-19 pandemic, to estimate differences in substance-using behaviors of those who were confirmed/probable cases of COVID-19 (based on self-report or medical record) and those who were not a confirmed/probable case, and to assess how PLWH and people who are at high risk for HIV in C3PNO have different experiences in and responses to the COVID-19 epidemic. The C3PNO Coordinating Center at The University of California, Los Angeles (UCLA) and Frontier Science will facilitate the design and implementation of a survey to collect data from a subset of participants from each of C3PNO cohorts (ACCESS, ALIVE, the Heart Study, HYM, JHHCC, MASH, mSTUDY, RADAR, and V- DUS). Cohorts will issue the survey to participants and transfer the resulting data to the coordinating center. If funded, this administrative supplement would allow a rapid and coordinated collection of linked COVID-19, HIV, and substance use data related to an ongoing public health emergency affecting the highly vulnerable substance- using populations followed by the cohorts. COVID-19 data harmonization with other HIV cohorts will further aide our collective effort to understand the impact of COVID-19 on these at risk communities. Finally, C3PNO's effort to assess changes in social and individual determinants of health, vaccine attitudes, differences in substance- using behavior, and the impact HIV-affected individuals during the course of the COVID-19 pandemic is both novel and critical in this time of unprecedented social upheaval and instability.

Public health relevance
PROJECT NARRATIVE Our U24 “Collaborating Consortium of Cohorts Producing NIDA Opportunities” (C3NPO) proposal brings together a team of researchers with global leadership in substance use, HIV prevention, clinical science and co-morbidities, immunology, modeling, bioethics, and bioinformatics to work with NIDA program scientists and stimulate the highest impact science across NIDA-funded HIV cohorts. The collaborative character of this proposing team offers the potential for new developments in bioinformatics techniques that allow integration of diverse and ever more massive sets of behavioral, clinical, and laboratory data for use by cohort and outside researchers. Thus, our proposal will address NIDA's 2016-2020 Strategic Plan priority focus areas and cross- cutting themes by leveraging technology, driving innovation, promoting collaboration, and encouraging data and resource sharing.